Macrophage-targeted dendrimer 2-PMPA for the treatment of age-related sarcopenia

PROJECT SUMMARY
Age-related loss of muscle mass, or sarcopenia, is a hallmark of aging that affects up to 20% of those over 65
and up to 50% of those over 80, for which there are no pharmacological treatments. We recently discovered that
the enzyme Glutamate Carboxypeptidase II (GCPII), which catalyzes the hydrolysis of N-acetylaspartylglutamate
(NAAG) to glutamate, is highly upregulated in activated macrophages infiltrating muscle during aging, and that
inhibiting the elevated GCPII activity with the inhibitor 2-PMPA (IC50 = 0.3nM) dramatically delays neuromuscular
junction (NMJ) denervation, and muscle function and volume loss. Unfortunately, 2-PMPA is not clinically
developable. It is highly polar, with negligible oral bioavailability (F<2%), a short half-life (<30m), and is active
only with high systemic (IP) doses. Given its significant clinical potential, we propose to address these limitations
by utilizing hydroxyl-dendrimers to facilitate its sustained and targeted delivery. Hydroxyl-dendrimers have shown
promise as targeted delivery systems due to their size (~4-10 nm) and surface attributes. They are rapidly cleared
from circulation under normal conditions but are selectively engulfed and retained by activated and phagocytic
immune cells under injury or inflammatory conditions. This is a very translational approach, as targeted
dendrimer delivery has been demonstrated to be efficacious in multiple animal models and recently shown to
reduce inflammation and mortality in a Ph2 clinical trial in hospitalized patients with severe Covid-19
(NCT04458298). We have assembled a highly experienced team with extensive expertise in neuromuscular
disorders and aging (Hoke), dendrimer nanoparticles (Kannan), and animal pharmacology, pharmacokinetics,
and clinical translation (Slusher). Together we plan to develop dendrimer-2PMPA (D-2PMPA) for age-related
sarcopenia by implementing the following aims: AIM 1. Synthesize and characterize generation 4 (G4) and
generation 6 (G6) D-2PMPA conjugates. AIM 2. Assess D-2PMPA (G4 and G6) pharmacokinetics, target
engagement, and biodistribution in aged mice. AIM 3. Evaluate the efficacy (behavioral, electrophysiological,
and histological) and tolerability of the selected D-2PMPA conjugate in aged mice. Successful execution of these
aims will result in a D-2PMPA conjugate ready for IND-enabling studies to support future clinical studies to
combat age-related sarcopenia.

Public health relevance
PROJECT NARRATIVE We recently discovered that the enzyme Glutamate Carboxypeptidase II (GCPII) is highly upregulated in activated macrophages infiltrating muscle during aging, and that inhibiting the elevated GCPII activity dramatically delays neuromuscular junction (NMJ) denervation, muscle function and muscle volume loss in aged mice. Unfortunately, there are no clinically available GCPII inhibitors as current inhibitors are polar and charged at physiological pH resulting in poor oral bioavailability and limited tissue penetration. Given its significant clinical potential, we propose to utilize a hydroxyl-dendrimer delivery system to provide sustained and targeted delivery of GCPII inhibitors to activated muscle macrophage; successful execution will result in an oral dendrimer-GCPII inhibitor conjugate ready for clinical translation to combat age-related sarcopenia.